Effects of global brain health on sensorimotor recovery after stroke

PROJECT SUMMARY
The neurobiology of post-stroke sensorimotor recovery is not fully understood. Current research on stroke
recovery focuses on two spatial levels of brain injury: the focal level (i.e., the lesion and brain structures directly
affected by the stroke, such as the corticospinal tract) and the network level (i.e., brain structures distant from
the lesion but affected via diaschisis). This proposal argues that a third level should be considered: global brain
health (GBH), which is defined as the cellular, structural, and vascular integrity of the whole brain. Although GBH
has recently been recognized as a crucial predictor of outcomes in conditions such as Alzheimer’s disease and
traumatic brain injury, its role in stroke recovery is not well understood. Similarly, although focal and network
effects of stroke injury have been well-studied, little is known about how stroke exerts global influences across
the whole brain. The key scientific premise of this research is that (a) GBH modulates the overall neuroplastic
resources that promote stroke recovery and (b) acute stroke injury causes global changes in brain health. The
central hypothesis is that poor GBH is related to poor stroke outcomes, and conversely, that severe acute stroke
injury is related to worsening of GBH. The rationale underlying the proposed research is that establishing GBH
as a meaningful contributor to stroke recovery may stimulate new avenues of research and novel targets for
therapeutic development. GBH will be estimated as indexed by four brain imaging measures linked to brain
health (predicted brain age reflecting structural atrophy, severity of deep white matter hyperintensities,
periventricular hyperintensities, and perivascular spaces). Aim 1 will utilize a large, retrospective stroke
neuroimaging and behavioral database from the ENIGMA Stroke Recovery working group (N=627) to
characterize the relationship between GBH and stroke outcomes in a cross-sectional chronic stroke population.
Aim 2 will use a prospective, multi-site, longitudinal data collection (N=144) in individuals within three weeks and
at three months after stroke to study how initial GBH relates to post-stroke brain repair and sensorimotor
recovery. Aim 3 will use the same prospective dataset (N=144) to examine how the severity of acute stroke
relates to longitudinal changes in GBH between 3 weeks and 3 months. With respect to key findings, we expect
to show that GBH is related to sensorimotor outcomes and predicts the extent of early stroke recovery, and that
GBH evolves in this context. The proposed work is innovative because it opens an entirely new framework in
which to consider sensorimotor recovery after stroke. The results are expected to have an impact because they
will advance our understanding of global influences on stroke recovery, and they will implicate GBH as a novel
therapeutic target for potentiating recovery after stroke.

Public health relevance
PROJECT NARRATIVE This research is relevant to public health because it will uncover new neurobiological influences on how people regain motor and sensory function after a stroke. Specifically, this study will examine the role of global brain health measures, which represent deterioration of systems across the whole brain, in stroke recovery by analyzing both: (a) a large existing database of neuroimaging and behavioral data on stroke patients and (b) new data that will be collected in the first 3 months following stroke, when the majority of stroke recovery is thought to occur. The project is relevant to the NIH’s mission because it will create important new knowledge on the relationships of global brain health to post-stroke brain injury, brain repair, and sensorimotor recovery, which can be used to identify novel therapeutic targets to improve stroke recovery.